Administrative Core

The Administrative Core (AC) of NeuroTech Harbor (NTH) will direct, coordinate, and lead the Outreach, Evaluation, Innovator, and Resource Cores to efficiently achieve the following goals: (i) Be a national leader in the support and development of real-world solutions to neurological problems. (ii) Act as an excellent steward of federal funds to achieve maximum return for NIH and society at large. The AC will consist of the Governing Board, Steering Committee, and Advisory Board. The AC will serve as a central leadership team that will continually assess, refine, and improve NTH processes to achieve better results. NTH’s AC will accomplish the following aims: (Aim 1) To ensure excellence in Governance and Management at NTH. (Aim 2) To coordinate all NTH Core interactions with the Steering Committee (SC), Advisory Board (AB), and Consultant Network. (Aim 3) To prepare NTH-selected meritorious innovation projects for NIH funding consideration and ensure success of funded projects. (Aim 4) To actively communicate best practices and collaborate across the BluePrint Hub consortium.
We have assembled a Governing Board led by NTH PIs serving as Directors of each Core. As the founding institutional partners of NTH, the Governing Board will be led jointly by Co-Chairmen Dean Schlesinger from JHU and Provost Dr. Wutoh from Howard. The Governing Board will ensure that NTH continues to meet milestones and benchmarks. The AC will also act as the final arbiter of conflicts and take action to maximize likelihood of success for NTH, Cores, and subprojects. While Core Directors will separately manage the budgets, personnel, processes, and goals for each Core, the AC will act as a central coordinator for all Cores to receive regular input and oversight from the SC and AB. The AC will consider appropriate SC members for (1) Outreach Core needs assessments and NTH solicitations, and (2) reviews with the Evaluation Core to ensure the highest impact innovation projects are selected.
The AC team will convene an annual Governing Board meeting with key AB members to continuously identify areas of improvement in quality, efficiency, outcomes, and responsiveness in response to the changing landscape of medical needs, technological breakthroughs, and scientific advancements in the neurology space. The AC will coordinate access to an external Consultant Network of experts who span a broad range of expertise (early-stage technology, clinical translation, or business development) to assemble the Dream Tech Team for each innovator project. In the Innovator Core will support innovators with the guidance and resources necessary for building solutions for optimal real-world impact. The AC will be responsible for coordinating interactions with NIH BluePrint (BP) program staff on strategic planning. In addition, the AC will work with each Core’s staff to collect, analyze, and disseminate our outcomes and best practices to the BP network.